Neural Mechanisms Underlying IC/BPS

Abstract
Interstitial cystitis/bladder pain syndromes (IC/BPS) is a debilitating condition with loss of bladder control and
severe bladder pain on bladder filling. Mechanisms underlying IC/BPS are poorly understood. Compelling studies
show that the brainstem via direct projection to the spinal cord can directly modulate nociceptive processing and
bladder function. In our preliminary studies, we have identified distinct populations of the brainstem neurons that
project to the spinal cord. Here we will determine the precise roles of these distinct brainstem neurons in the
pathology of IC/BPS. We will determine if IC/BPS leads to maladaptive changes in these distinct populations.
We will use optogenetics, anatomical tracing, in vivo calcium imaging, slice electrophysiology and RNA
sequencing to determine if IC/BPS leads to functional changes at the cellular and systems level in these circuits.
Do these changes drive IC/BPS? Does reversing these maladaptive changes relieve IC/BPS? Together, this
work will reveal the specific roles for this neural circuits in IC/BPS. This rich information can have broad
implications for potential new direction in designing safer therapeutic drugs in treatment of the IC/BPS.

Public health relevance
Project Narrative This proposal will study neural circuits in the brainstem and spinal cord that process IC/BPS. A better understanding of the mechanisms of these circuits would greatly aid our ability to develop therapies for the treatment of IC/BPS.